Adapt innovative deep learning methods from breast cancer to Alzheimers disease

Adapt innovative deep learning methods from breast cancer to Alzheimer’s disease
Abstract
Alzheimer’s disease (AD) is the most common form of dementia, with the number of affected Americans
expected to reach 13.4 million by the year 2050. Early detection and treatment of AD is critical to prevent non-
reversible and fatal brain damage. Thus, development of non-invasive markers from neuroimaging modalities
(e.g., brain MRI) is of great significance for screening and early detection of AD. In the PI’s active R01 award
(1R01EB032896-01), the research focuses on developing a new line of research strategy and technical
innovation to analyze breast cancer images for diagnosis, risk prediction, and triage. The core strategy is to
incorporate medical/clinical intelligence into data-driven deep learning modeling. This technical innovation is
however not limited to breast cancer, but can be adapted to other diseases, such as AD, as well. Thus, in this
Supplement proposal, we propose to develop an AD focus of our active R01 by adapting the new technical
innovation in breast cancer into cognitive outcome prediction for discovering early and no-invasive imaging
biomarkers for AD. The main task of this Supplement study is to build deep learning models using brain MRIs
as input for cognitive outcome prediction, which is formulated as a typical classification problem among three
cognitive classes: Normal Control vs. Mild Cognitive Impairment vs. AD. We proposed two specific aims: 1)
Deep curriculum learning informed by samples’ characteristic knowledge for cognitive outcome prediction and
2) Learning knowledge from longitudinal brain MRIs to improve prediction of AD. We will mainly use the
publicly available Alzheimer’s Disease Neuroimaging Initiative (ADNI) dataset. We have assembled a multi-
disciplinary team with complementary expertise. The proposed study will provide an avenue to translate some
of the innovative techniques developed in other domains to advance non-invasive imaging biomarker
development for AD. This project will also provide an opportunity for the PI’s team to get involved and
contribute to AD-related new research.

Public health relevance
Public Health Relevance Statement (Project Narrative): Alzheimer’s disease (AD) is the most common form of dementia. Early detection and treatment of AD is critical to prevent non-reversible and fatal brain damage. We propose to adapt and develop new technical innovation in breast cancer imaging into cognitive outcome prediction for discovering early and no-invasive imaging biomarkers for AD. This study will provide an avenue to translate some of the innovative techniques developed in other domains to advance research progress in the AD field.